ASBMR-RBDA Three-Year Rare Bone Disease Symposia

The American Society for Bone and Mineral Research (ASBMR) is the largest professional, scientific and medical
society established to bring together clinical and laboratory-based investigators who are involved in the study of
bone, mineral and musculoskeletal disorders. Since 2002, the ASBMR has held one-day symposia preceding
the society Annual Meeting that were funded by an R13 grant, tackled a specific topic and were very successful.
Based on that strength, the ASBMR subsequently received 3-year R13 grants to systematically organize topical
symposia for 2016-2018, 2019-2021 and 2022-2024. In that vein, the present application seeks a 3-year R13
grant to organize annual one-day symposia on Rare Bone Diseases, in partnership with the Rare Bone Disease
Alliance. This is a critical and compelling field of research in urgent need of basic, transitional and clinical
advances. The 2024, 2025 and 2026 symposia will respectively focus on: 1) “Exploring and Expanding
Treatments and Analytical Tools in Rare Bone Diseases”; 2) “From the Genome to the Lived Experience”; 3) “A
Review of the Rapidly Changing Landscape in Rare Disease Therapeutics”. The three symposia cover most
pressing and timely areas of musculoskeletal research that are undergoing rapid advances in scientific
knowledge and address disorders with major clinical morbidity, disability and mortality. The overall objective of
this R13 is to share and discuss most recent findings and envision paths to translation and clinical testing of new
therapies, with the goal of improving care of patients with rare bone diseases. The symposia will gather the best
researchers, present state-of-the-art findings in each topic area, foster interactions and collaborations between
young and established investigators, and chart future goals and directions. The symposia will also provide a
forum to learn of novel strategies pursued in other research fields and their potential to expand rare bone disease
research and therapeutic horizons. Symposia attendees will be encouraged to stay and take part in the Annual
Meeting to further interact with musculoskeletal researchers, establish additional connections and learn from
common bone diseases. Programs for all three symposia were developed by an organizing committee, and
speakers for the first two symposia have confirmed their participation. Presenters will include established and
young investigators, women and men, and national and international participants. There will be poster sessions
and preference will be given to young investigators to present their abstract orally to further facilitate and
encourage direct interactions between young and senior investigators. The 2024 symposium will discuss latest
advances on the pathogenesis and potential treatments of rare bone diseases and will explore novel therapeutic
strategies and future analytical tools by including experts from academia, industry and government entities. In
2025, the symposium will go from bench to bedside and feature an array of speakers who will be covering topics
that span the genome to the patient voice through their lived experiences. The 2026 symposium will review the
rapidly changing landscape of rare bone disease therapeutics and feature a diverse group of speakers including
patients, researchers from academia and industry, and government officials.

Public health relevance
This application seeks funding for a three-year R13 grant to advance the field of rare bone diseases by focusing on three specific areas of biomedical research: 1) “Exploring and Expanding Treatments and Analytical Tools in Rare Bone Diseases”; 2) “From the Genome to the Lived Experience”; 3) “A Review of the Rapidly Changing Landscape in Rare Disease Therapeutics”. These three areas cover a range of rare musculoskeletal diseases that collectively contribute to major clinical morbidity, disability and mortality. The overall objective of this R13 is to advance basic and translational research and identify novel therapeutic and analytical tools by including the best researchers for each of the three symposia, held in conjunction with the Annual Meeting of the American Society for Bone and Mineral Research, the largest professional, scientific and medical society of clinical and laboratory-based scientists and clinician-scientists involved in the study of bone, mineral and musculoskeletal disorders.